Neurobiology and Treatment of Reading Disability in NF1

PROJECT SUMMARY/ABSTRACT
Neurofibromatosis Type 1 (NF1), an autosomal dominant neurocutaneous syndrome with an incidence of
1:3000, is caused by a mutation in neurofibromin -- a protein that negatively impacts learning by altering RAS
signaling in long term potentiation (LTP). Clinically, NF1 shows four times greater rate of learning disabilities
(65%) compared to the general population (15%), including reading disability (RD), resulting in educational
impairment. The negative impact on academics makes these learning disabilities, including reading disability,
among the most common concerns of parents of children with NF1. In previous research (NS49096), we
demonstrated that children with NF-1 with reading difficulty (NF+RD) are able to respond to standard
phonologically-based reading tutoring that was originally developed to treat children in the general population
with idiopathic reading disability (IRD). Of central importance to this application, another line of research in the
mouse model of NF has shown that pharmacological treatment (Lovastatin) reverses learning deficits (Li et al.,
2005). The assumed mechanism is that Lovastatin, an HMGCoA reductase inhibitor, upregulates RAS
signaling to counteract the negative LTP effects of deficient neurofibromin, thus allowing for better memory
formation during learning. This finding has stimulated translational research to assess whether Lovastatin, a
medication that the American Academy of Pediatrics to endorses as safe to use in children, can reverse
cognitive deficits in humans with NF1. Promising results have been found in studies that, similar to the mouse
studies, measure specific cognitive domains or pair Lovastatin with training of the deficient skill. Given that (a)
NF+RD benefit from reading tutoring and (b) pharmaceutical benefits appear linked to specific study designs,
several next steps are needed to better understand the behavioral and neural mechanisms of cognition in NF1.
Specifically, we propose a clinical trial in which we pre-treat the NF+RD children with Lovastatin for the 12
weeks prior to reading tutoring, as compared to NF+RD who receive either reading tutoring or Lovastatin;
critically, like animal studies, we will target those who show impaired learning on the specific skill to be taught,
i.e., NF+RD will receive reading tutoring. Both behavioral and neurobiological measures are proposed, and
changes in functional and structural connectivity are expected to occur with enhanced cognition. In particular,
the combination of behavioral and pharmacological intervention is hypothesized to have a synergistic effect
producing greater gains in cognition and changes in neurobiology than Lovastatin or tutoring alone. In sum,
our overarching goal in this next phase of our research is to capitalize on current findings to elucidate
mechanisms of and best treatments for the cognitive deficits in NF1. Such approach could also have a
broader applicability for better understanding human learning mechanisms in developmental disorders.

Public health relevance
PROJECT NARRATIVE Neurofibromatosis Type 1 (NF1) is a common genetic disorder that is associated with a four times greater risk of learning disabilities, including reading disabilities, and a deficiency of neurofibromin – a protein important in a signaling pathway that regulates learning and memory. Our previous work (NS49096) demonstrated that school-age children with NF+RD can respond to standard phonologically-based reading tutoring originally developed to treat reading disability in the general population. Combining our work with that by other researchers suggesting that a medication (Lovastatin) may counteract the effects of the deficient neurofibromin, and possibly ameliorate learning disabilities in NF1, we propose to examine the synergistic effects of medication plus reading tutoring.